EFFECT OF SOMAVERT ON INSULIN SENSITIVITY IN TYPE II DIABETES

Determine whether blocking growth hormone effects can improve the action of insulin and help to lower the blood sugar levels in people with NIDDM.